THE INFORMATICS, DATA ANALYSIS, AND STATISTICS CORE (IDASC)

ABSTRACT FOR IDASC
The Informatics, Data Analysis, and Statistics Core (IDASC) will implement the Human Connectome Project’s
data analysis approach for the Aging Adult Brain Connectome (AABC) Project’s multi-modal imaging data. It will
archive the imaging data as it is collected by the Integrated Data Acquisition Core (IDAC) and provide feedback
to the IDAC on any data quality concerns as a part of its initial quality control. The IDASC will also curate and
manage biological, sociological, and behavioral measures from the Genetics and Multi-omics Specimens Core
(GMSC) and IDAC. The HCP’s brain imaging preprocessing pipelines will be run on the imaging data when it
has been accepted by the database. This includes preprocessing for structural, functional, diffusion, and ASL
MRI data. The IDASC will then perform quality control on these preprocessing results. The IDASC will also
develop cross-sectional and longitudinal data analysis pipelines to generate multi-modal Imaging Data
Phenotypes (IDPs) representing brain architectural/morphometric, functional, and connectivity measures at the
levels of brain areas, functional networks, and white matter tracts. Using these imaging measures together with
the biological, sociological, and behavioral measures collected and generated by the IDAC and GMSC, the
IDASC will assist the 4 sub-projects with generation of optimized longitudinal statistical models to address their
specific hypotheses about interactions between brain, behavior/sociological, and biological factors that
contribute to Alzheimer’s Disease (AD) or other dementias. The IDASC will also share data at the conclusion of
the project.

Public health relevance
NARRATIVE The informatics, data analysis, and statistics core for the aging adult brain connectome project will: (1) Archive the imaging data and behavioral and biological measures in a database. (2) Perform quality control on the brain image data. (3) Develop and maintain brain imaging analysis pipelines, including analyses across subjects and within subjects across time, for multiple imaging modalities including those measuring brain structure, function, and connectivity to produce imaging-based measures for each subject and timepoint. (4) Perform optimized statistical analyses of biological, behavioral, and imaging-based measures together with the four sub-projects.